Oncogenic functions of mutant p53

Abstract
The tumor suppressor gene, p53, has pleiotropic functions that quash tumor development.
One of its most important functions is to prevent the genome from sustaining DNA damage in
order to prevent the propagation of genetic lesions into daughter cells. Given the high degree of
genetic alterations in cancer, it is not surprising that p53 is frequently inactivated. The most
common form of genetic lesions in the p53 gene are point mutations in the DNA binding domain.
These missense mutations typically inactivate the p53’s tumor suppressor activity while
simultaneously generating an oncogenic protein. The presence of mutant p53 correlates with
increased chromosomal instability leading to loss of tumor suppressor genes and amplification of
oncogenes. It has become increasingly recognized that the cGAS/STING/TBK1/IRF3 innate
immune response signaling pathway plays a crucial role in detecting genetic alterations and
launching cell intrinsic and extrinsic responses to suppress aberrant cells that harbor genetic
defects. In this proposal, we that mutant p53 suppresses signaling through the cGAS/STING
pathway and thereby dictates how cells respond to its activation. We propose three aims to
determine the mechanism by which mutant p53 controls cGAS/STING signaling, and the cell
intrinsic and extrinsic consequences of modulation of this pathway. The completion of these
studies will help guide how to therapeutically approach cancers based on their p53 status.

Public health relevance
Project Narrative One of the most frequently mutated genes in human cancer is the TP53 gene. We have found that the mutant form of p53 promotes tumor development by suppressing the innate immune response pathway. We seek to understand how this occurs and to try various strategies to reactivate this pathway.